Sex differences in cerebral pulsatility and implications for brain health

PROJECT SUMMARY
Pulsatility is a measure of fluctuations in flow over the duration of a cardiac cycle. Increases in pulsatility in the
cerebral vessels with advancing age have been linked to structural damage in the brain. Cerebral pulsatility is
elevated in patients with vascular dementia and Alzheimer’s disease. The goal of our research is to understand
age-related changes in cerebral blood flow regulation, how this impacts global and regional perfusion of the
brain, and determine successful interventions for improving cerebral blood flow control. In order to understand
age-related changes, it is critical to take into account sex differences and how the trajectory of these changes
may differ between men and women. Our preliminary data shows that the rate of increase in cerebral pulsatility
over the human lifespan is greater in women compared with men. This work suggests that women may be more
vulnerable to changes in cerebral pulsatility with advancing age. In the parent grant, we have state-of-the-art
neuroimaging tools available to assess cerebral pulsatility in multiple cerebral vessels in a large cohort of middle-
aged and older adults. Therefore, the objectives of this supplement application are to leverage existing MRI
scans to investigate biological sex differences in cerebral pulsatility. Our hypothesis is that there are sex
differences in cerebral pulsatility that impact brain health. Importantly, this project will be the first to investigate
sex differences in cerebral pulsatility and determine associations with neurobiological markers of brain health.
Aim 1 will determine if there are sex differences in cerebral pulsatility in multiple intracranial arteries. Aim 2 will
explore the influence of vascular risk factors and physical activity on cerebral pulsatility. Aim 3 will determine the
impact of cerebral pulsatility on neurobiological markers of brain health and Alzheimer’s disease and then
determine if these relationships are sex-specific. This project will provide essential information to determine sex
differences in cerebral pulsatility. It will also explore the influence of physical activity and other vascular risk
factors, and determine potential sex-specific associations with neurobiological markers of brain health that are
important for the risk of Alzheimer’s disease and dementia. To achieve these aims, we will employ innovative
MRI analysis from existing neuroimaging scans in a large cohort of middle-aged and older adults. This application
aligns with recent recommendations published by the NIH emphasizing the need for human studies to identify
and confirm biomarkers of vascular processes related to cognitive impairment. Upon completion, we will
understand whether sex differences in cerebral pulsatility are contributing to a greater risk for Alzheimer’s
disease and related dementias.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it investigates a potential new risk factor for cerebrovascular health. Upon completion, we will determine whether sex differences in cerebral pulsatility have an impact on neurobiological markers of brain health that are relevant to cognitive decline. The project is relevant to the NIH’s mission because it will provide fundamental knowledge about sex differences in brain health in humans and reduce disability associated with cognitive impairment.